CU Boulder Center for Cryo-ET (CCET)

We will establish a satellite service center within a larger network according to RFAs RM-
19-009 and -010, named the CU-Boulder Center for Cryo-Electron Tomography (CCET). Our
satellite will focus on cryo-specimen preparation and cryo-electron tomography (cryo-ET) applied
to cells, organelles and large supramolecular assemblies. The applicants combine the expertise
of three P.I.s, Michael Stowell (high-resolution cryo-electron microscopy (cryo-EM)), Karolin Luger
(biochemistry of large complex assemblies, especially protein-nucleic acid interactions), and
Andreas Hoenger (former P41 director, cryo-EM and cryo-ET from macromolecules to cells and
tissues). With our current staff, we combine extensive expertise with cryo-ET and relevant
software. We will offer a broad range of cryo-electron microscopy (cryo-EM) and cryo-ET
preparation procedures for cellular structures and intracellular macromolecular assemblies, as
well as training opportunities for scientists who would like to establish these technologies, or at
least part of them, for their home labs. Here in Boulder, we have several high-end microscopes
available, including a newly installed Titan-Krios. Three of our microscopes are equipped with
direct electron detectors. In addition, we have a comprehensive periphery for cryo-specimen
preparation, storage, and handling resources, including computational tools. We will add cryo-
Focused Ion Beam (cryo-FIB) milling to produce vitrified lamellae of cells and tissues. We
propose the following organization of the facility: Specific Aim 1: Cryo-ET specimen
preparation methods offered for service: Our technology and expertise will be made
accessible for our users and for further collaborations with the data collection hub proposed in a
parallel RFA (RM-19-010). Specific Aim 2: Cross-training opportunities for service users:
We will offer comprehensive training for users, including one-on-one instruction on microscopes
and related equipment. As appropriate, we will pool users into small groups and run a training
week as a hands-on workshop on equipment as well as related software developed by our facility
such as Serial-EM, IMOD and PEET. While the emphasis with training will be on practical aspects
of specimen preparation and data collection, we often encounter novice users in strong need for
a thorough introduction into image analysis software as well. Specific Aim 3: Administration
and organization of the facility: Users, assigned to us via the network-wide application process
will have the opportunity to participate in the specimen refinement process, and receive training
on the cryo-ET processes involved. Projects with high potential will be referred for high-
throughput data collection to the central hub facility of the network. Boulder, Colorado is centrally
located and well-connected nationwide through Denver International Airport.
This supplement will provide two instruments that are vital for meeting user demand in
sample preparation and increasing the center’s overall throughput. The PRIMO system’s precise
cell positioning, combined with the MICA system’s ability to accurately capture critical cellular
events, will both streamline sample processing and greatly improve experimental outcomes by
pinpointing key biological timepoints more effectively

Public health relevance
This supplement will expand the capabilities of CCET by key equipment for cell positioning and live cell imaging that will be integrated with current CLEM instrumentation to improve user throughput and success.